Anxiety and Interoception Risk for Eating Disorders in Childhood

PROJECT SUMMARY/ABSTRACT
Out of 100,000 children and adolescents, 120 will have Down Syndrome, 56 will die from
sudden infant death syndrome, 15 will be diagnosed with cancer, 12 will develop Type II
diabetes, and 2,900 will have an eating disorder (ED). Although the age of onset for EDs was
traditionally observed in adolescence, onset is occurring younger, with many children
developing EDs by age 12. Estimates suggest there will be 1.9 million new cases of youth EDs
by 2024. Despite the high prevalence, costs, impairment, and deaths from EDs, there is very
little knowledge on what predisposes children to develop EDs. Importantly, early detection and
intervention is crucial: problematic eating behaviors can damage developing brains and bodies,
and untreated EDs carry significant risk for becoming lifelong chronic health conditions,
associated with high mortality rates, societal and personal burden. Our scientific premise,
developed from our past work, is that anxiety and interoceptive deficits (inaccuracy identifying
bodily sensations, heightened or blunted sensitivity to these sensations), as well as deficits in
fear learning underlying anxiety and interoceptive deficits, will predict common, problematic
eating behaviors and cognitions (e.g., restriction, body dissatisfaction, cognitive restraint), as
well as clinical EDs. Our study goals are to (1) test if childhood anxiety and interoceptive deficits
are risk factors for problematic eating behaviors and cognitions and EDs and (2) test if deficits in
fear learning are a mechanism by which anxiety and interoceptive deficits contribute to risk.
These goals will ultimately lead to (a) tools that can better detect childhood risk factors for EDs
and (b) prevention efforts directly targeting mechanisms predictive of ED onset. The proposed
research uses innovative parent-report momentary assessment combined with well-established
diagnostic, behavioral, observational, and physiological assessment. We will recruit a sample of
400 girls across two age cohorts (6-8; 10-12 years old) enriched for interoceptive deficits,
anxiety, and EDs; 75% (n=300) will be recruited based on maternal history of EDs or anxiety,
and 25% (n=100) will make up the control group. This study will, for the first time, allow us to
begin to quantify how early symptoms of ED develop. The specific aims are to test (1) multi-
modal aspects of anxiety and (2) characteristics of interoceptive deficits that may prospectively
predict problematic eating behaviors and cognitions and EDs, and (3) mechanisms of prediction
among anxiety and interoceptive deficits. The proposed research has clinical impact: ultimately,
this study will lead to early detection and prevention of EDs in childhood and beyond, averting
the large personal and societal costs associated with both childhood onset and chronic EDs.

Public health relevance
PROJECT NARRATIVE This project will collect data on early childhood risk factors for eating disorders in female children ages 6-12. The proposed research has significant public health relevance, as it will enhance our understanding of how eating disorders develop and for whom, leading to early detection and prevention efforts. The proposed research is relevant to NIMH’s strategic aim 3.1. A to strive for prevention based on an understanding of risk, as it will lead to tools that can better identify early risk factors, as well as prevention efforts directly targeting mechanisms predictive of the onset of early eating disorders and related pathology.